Molecular Mechanisms of Wnt Transport

ABSTRACT
Wnts are a family of evolutionary conserved, secreted ligands that act at short range to coordinate morphogenetic
movements and cell fate decisions. Secretion of Wnt and subsequent recognition by its cognate receptor require
its O-palmitoleation in the endoplasmic reticulum. This modification is carried out by PORCN, that then transfers
Wnt to WLS, its dedicated integral membrane transporter. How WLS associates with Wnt in the ER, and
subsequently delivers it to the receptor Frizzled on the receiving cell remains largely unknown, and is the focus
of this Application.
Currently, there is a limited understanding of how WLS binds Wnts and transport them to the cell membrane.
Here we present as recently published data the structure of human WLS, in a complex with WNT8A, determined
using single-particle cryo-electron microscopy to 3.2 Å resolution. The WLS membrane domain resembles a G
protein-coupled receptor (GPCR), albeit with one additional transmembrane helix. The O-palmitoleated Wnt
hairpin loop 2 inserts into a conserved central cavity of the GPCR-related domain, with the attached palmitoleate
protruding out into the lipid bilayer. Highly conserved patches on the outward-facing surfaces of the
transmembrane domain of WLS, adjacent to a hydrophobic gateway, suggest potential mechanisms for Wnt
transfer from PORCN and to Frizzled.
We propose to further study the interaction between WLS and Wnt, using the available structural information as
starting point. First, we will investigate how Wnt associate with WLS. We propose to determine the structure of
WLS in its apo – absent Wnt – state, as well as probe the putative site of entrance of Wnt into WLS by structure-
guided mutagenesis and biochemical assays. Our preliminary results suggest a direct interaction between WLS
and PORCN. Second, we will test how changes in sequence and glycosylation pattern can affect Wnt secretion
and destination, as well as the effect of pH on the interaction between the two proteins, using structure-guided
mutagenesis as well as Wnt transport and delivery assays in primary intestinal cells. Third, we propose to study
the release of Wnt to subsequent receptors. Our preliminary results suggest a direct interaction between WLS
and the Frizzled receptor, and we will test this hypothesis using detailed structure function analyses.

Public health relevance
NARRATIVE Wnts are evolutionarily conserved ligands that signal at short range to regulate morphogenesis, cell fate and stem cell renewal. This application will provide a molecular understanding of the how Wnts are secreted from the endoplasmic reticulum to the cell surface by binding their dedicated transporter protein WLS. We have determined the atomic resolution structure of Wnt in complex with WLS, using cutting-edge single-particle cryo-electron microscopy and we propose to contribute additional structures as well as employ a range of biochemical and cell-based experiments to study how Wnts bind to WLS, are transported, and dissociate from WLS to reach their target cells for signaling.